NorthStar Node of the Clinical Trials Network: Engaging African American Faith-Based Leaders in a Substance Use Learning Collaborative (LC)

Project Summary/Abstract: Project title: Engaging African American Faith-based leaders in a substance use Learning Collaborative (LC) The University of Missouri, Kansas City, Collaborative to Advance Health Services (CAHS) is collaborating with Hennepin Healthcare Research Institute, National Institute on Drug Abuse (NIDA), Clinical Trail Network (CTN) Northstar Node and Morehouse School of Medicine to conduct a pilot study to increase access to Substance Use Disorder (SUD) care for African Americans by engaging faith-based Leaders (FBLs) through a learning collaborative (LC) model. Based on the Institute for Healthcare Improvement (IHI) model, a LC is a short-term (6- to 15-month) learning system that brings together teams (e.g., FBLs, community members, behavioral health/SUD and social service providers) to seek improvement in a focused topic area (Hoge et al., 2020; IHI, 2003). The overall goal of this project is to increase FBLs knowledge of substance use and SUDs and to assess FBLs perceptions of engaging with BHPs by implementing an existing LC curriculum. This pilot exploratory project will pave the way for future initiatives focused on increasing SUD care in underserved Black communities through collaborations between FBLs and BHPs.

Public health relevance
Black communities are disproportionately impacted by opioid use disorder and marginalized from healthcare. The Black church is a trusted agent in the Black community and may serve as an important bridge to addressing opioid use disorder and linking community members to care. Our proposed faith-based leaders learning community focused on opioid use disorder and behavioral health has the potential to identify specific facilitators that increase access and engagement with the Black community and behavioral health providers and thereby address the Surgeon General's call for healthcare connecting with the wider community (SAMHSA, 2016).